Functional Role of O-glycosylation of HIV-1

Project Summary/Abstract
While N-linked carbohydrate is known to comprise a significant portion of the mass of HIV-1 envelope
protein, the dogma has been that O-linked carbohydrate is absent from HIV-1 envelope protein. The
Desrosiers laboratory has now shown unambiguously that a subset of HIV-1 isolates have O-linked
carbohydrate on the V1 region of their gp120 surface glycoprotein. Furthermore, this O-linked carbohydrate is
able to shield virus from recognition by potent broadly-neutralizing antibodies of the V3-glycan class. Our
results suggest that long V1 regions, sometimes with sometimes without O-linked glycosylation, can emerge as
a mechanism to escape neutralizing antibodies similar to the V3-glycan monoclonal antibodies that have been
defined to date. Our proposed studies will better define the characteristics of V1 region sequences that are
predictive of whether an individual sequence is likely to be O-glycosylated. We will determine whether there is
specificity to the blocking effects, i.e. whether one O-glycosylated V1 region potently blocks recognition by one
V3-glycan mAb but not another while a different O-glycosylated V1 region may have different specificities to its
blocking effects. We will use experimental SHIV infection of rhesus monkeys to examine whether there is
selective disadvantage to such long O-glycosylated V1 regions in the absence of such antibodies and to
examine the types of selective pressure that may drive elongation and O-glycosylation of V1 regions.

Public health relevance
Project Narrative The amazing collection of monoclonal antibodies with potent neutralizing activity against a broad range of HIV-1 isolates has stimulated great interest in their use for therapeutic and for prevention purposes, whether by passive administration or by long-term delivery with vectors such as adeno-associated virus. As use of such monoclonal antibodies in people increases, it will be important to understand the nature of different resistance mutations and the selective pressures driving certain types of sequence changes.